CENTER OF EXCELLENCE IN DIABETES AND OBESITY RESEARCH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Administrative Core (Core A) provides scientific, mentoring, budgetary, administrative, logisitic and statistical oversight to all aspects of the Diabetes and Obesity Center of Biomedical Research Excellence (DOC-COBRE)The Core Leaders - Dr. Aruni Bhatnagar and Dr. Roberto Bolli, Director and Co-Directors of the Center with assistance from Ms. Samantha Clausi the COBRE Administrator are responsible for all administrative activities for the COBRE.